Nephrotoxic Acute Kidney Injury in Veterans

Acute kidney injury (AKI) occurs in 20-25% of inpatient Veterans and is associated with substantial increases in
short-term mortality, and in long-term rates of chronic kidney disease (CKD), cardiovascular disease (CVD), and
death. The use of nephrotoxic medication is involved in a quarter of all AKI events, and the combination of high
incidence and poor outcomes makes nephrotoxin-associated AKI (NA-AKI) a major VHA health problem. This
proposal seeks to address major gaps in our understanding of NA-AKI among Veterans, while also equipping
the applicant with skills in machine learning (ML) including interpretable learning and incorporation of longitudinal
modeling and translational testing to ensure that models link to important long-term outcomes and to underlying
kidney pathophysiology, as well as skills to prepare the candidate for future multi-site deployment and
surveillance of calibration drift. There are no specific treatments after AKI onset, so prevention is the primary
means of addressing this disease. NA-AKI is the subtype most amenable to early intervention since medication
use is entirely within the purview of the hospital team; however, given the ubiquity of nephrotoxic medication
usage within VHA, it is important to identify those patients who are at highest risk. Machine learning is well-suited
to parsing the enormous number of variables associated with NA-AKI. In Aim 1 we will use VHA data including
patient factors, illness-related factors, and medication data to build machine learning algorithms that can
accurately determine which Veterans are most likely to develop NA-AKI. While accurate ML models have been
developed for other AKI subtypes, loss of performance at heterogenous sites and loss of calibration over time
have hindered widespread adoption. Aim 1 will therefore prepare the candidate to use federated learning and
data-driven calibration drift surveillance to overcome these barriers. Secondly, simply predicting a change in
creatinine, the most commonly used definition of AKI, can be overly simplistic and not linked to long-term or
clinically relevant disease. In Aims 2 and 3 we will use interpretable learning and incorporation of longitudinal
modeling and translational testing to enhance the ML algorithm’s prediction of clinically meaningful AKI. In the
short-term, completion of these Aims will position the applicant for a post-CDA grant proposal to develop a
systematic approach to NA-AKI prevention that couples ML learning, AKI biomarkers, and clinical interventions
to reduce nephrotoxin exposure in high-risk Veterans, and also a post-CDA grant expanding the use of AKI
biomarkers so that ML algorithms can predict tubular injury specifically. My long-term goal is to improve outcomes
among Veterans with kidney diseases by increasing the efficacy of VA nephrologists. Nephrology is a heavily
lab-dependent specialty, and there is tremendous potential to use electronic medical record data, machine
learning algorithms, and novel laboratory markers to increase the scope of care that can be provided. I would
like to develop an approach to AKI and other kidney diseases that doesn’t await consultation, but rather one that
proactively identifies and intervenes in the care of high-risk hospitalized Veterans. In order to accomplish these
long-term goals, I will need a complementary set of skills in biomedical informatics and machine learning,
translational medicine, and longitudinal modeling. The CDA-2 award period will build upon my subject matter
expertise in NA-AKI and masters-level training in translational research, and will add expertise in health
informatics with an emphasis on machine learning. These skills will be developed through focused didactic
classwork through the Masters of Business Analytics (given the prominence of the University of Iowa Hospital
system on campus, nearly half of all projects relate to clinical decision making) coupled with e-learning modules
on how to successfully prepare data from the VHA. This career plan will be guided by a multi-disciplinary mentor
team with complementary expertise in all training and research areas, which will prepare me for a productive
long-term career within the VA using ML informed by longitudinal analysis and translational testing, paired with
existing skills implementing clinical interventions, preventing AKI and other kidney diseases in high-risk Veterans.

Public health relevance
Acute kidney injury (AKI) occurs in 20-25% of hospitalized Veterans and is associated with substantial increases in short-term and long-term morbidity and mortality. A quarter of all AKI events are due to nephrotoxin use, making nephrotoxin-associated AKI (NA-AKI) one of the most common and serious treatment-related complications among Veterans. Because there are no specific therapies for NA-AKI once it has occurred, systems to identify high-risk Veterans and intervene before AKI occurs are desperately needed, but currently do not exist. This research seeks to 1) use machine learning (ML) methods to identify high-risk Veterans, 2) prepare for deployment of the ML algorithm while maintaining performance at heterogenous sites and over time, and 3) use interpretable learning, longitudinal modeling, and novel AKI biomarkers to link ML outputs to meaningful long-term Veteran outcomes and underlying kidney pathophysiology. These findings will be the foundation of future grants to intervene in high-risk Veterans in order to prevent NA-AKI.